West Virginia Manufactured Food Regulatory Program Standard Compliance and Enforcement Expansion

West Virginia Manufactured Food Regulatory Program Standard Compliance and Enforcement
Expansion: Project Summary
The primary purpose of West Virginia Manufactured Food Regulatory Program Standard Compliance and
Enforcement Expansion project is to ensure that the WV DHHR, Bureau of Public Health, Office of
Environmental Services, Public Health Sanitation Division’s Manufactured Food Program is adequately
staffed to continue to meet program standards and enhance compliance and enforcement capacities.
On July 1, 2022, WV §64 CSR 43 Food Manufacturing Facilities will be effective and adopt 21 CFR 117
Process Controls and Good Manufacturing Practices for Human and Animal Foods by reference. The
update to the state rule will result in changes to inspection methods, time utilization, compliance and
enforcement expectations, and reporting methods. The result will be a stronger program that will utilize
more laboratory evidence to back compliance and enforcement actions.

Public health relevance
West Virginia Manufactured Food Regulatory Program Standard Compliance and Enforcement Expansion: Project Narrative WV Manufactured Food Regulatory Program has identified two gaps that may impact alignment with Manufactured Food Regulatory Program Standards during routine standards review. The first gap is alignment with MFRPS Standard 1 for rules and regulations pertaining to the adoption of FDA’s 21 CFR 117 Current Good Manufacturing Practice, Hazard Analysis, and Risk-Based Preventive Controls for Human Food. The second gap relates to alignment with staffing levels as outlined in MFRPS Standard 8. The first gap is being addressed by current legislation in the 2022 WV Legislative Session DHHR submitted an update to the state rule and the Legislature approved the changes. On July 1, 2022, WV Rule §64 CSR 43 Food Manufacturing Facilities will change to incorporate FDA 21 CFR 117 by reference. This change will require WV MFRPS field staff to focus more on a risk-based approach to manufactured food inspections resulting in longer inspections. The change also is an opportunity to bring inspection reports into better alignment with FDA standards which will allow for greater mutual reliance between FDA and WV DHHR. As WV DHHR begins to focus on a risk-based approach to conduct inspections the program will also change the compliance and enforcement approach to utilize environmental and finished product sampling to gather laboratory data to help facilitate and inform compliance and enforcement actions taken in response to repeat violations that are critical in nature. This risk-based approach will help protect and promote the safety of food coming from WV Food Manufacturers, but it will also result in more time spent conducting inspections and follow-up at facilities. Recent MFRPS Standard 8 review calculated that WV would need 4.3 full-time equivalent field inspectors to conduct the number of inspections required by our rule and standard. Present staffing level finds that while we have six currently trained staff that can actively conduct field work, they only meet the time needed for a level of about 2 full-time equivalent field staff. All staff currently working in the MFRPS program and the staff in training to work in the MFRPS program are also assigned other job duties that at certain times during the year take precedence and inhibit their work in the MFRPS program. Two of the six staff work in an administrative capacity for DHHR and four work at a district level with field responsibilities in multiple DHHR programs. The gap in staffing level has been recognized and presented to leadership as an issue. Leadership has agreed that there is a need to hire two dedicated MFRPS Inspectors to help address this gap. One of the obstacles to creating new positions within this program is funding. Manufactured food permit fees generate around $21,674. This number depends on the amount and size of the facilities permitted. Funding two new positions will cost around $154,469. This grant will help offset some of the cost hiring new staff would create for the program and allow DHHR time to find state funding streams for long term staffing plans. This will help WV navigate the challenges presented by updating the state rule and keep us aligned with two MFRPS standard and expand our work in Standard 10.